Cytometry and Antibody Technology

ABSTRACT
The Cytometry and Antibody Technology (CAT) Facility’s mission is to support the community of researchers
at the University of Chicago with: 1) cutting-edge technology operated by expertly trained personnel; 2) high-
quality analytical monoclonal antibodies; and 3) expert technical consultation and training of researchers. The
Facility is utilized by University of Chicago Medicine Comprehensive Cancer Center (UCCCC) investigators
conducting basic and translational research of cellular phenotype and function. The CAT Facility serves the
UCCCC membership by providing tools necessary to measure the properties of cells and their products. This
includes the technology and staff expertise to use these reagents for experimental measurements (flow
cytometers, mass cytometer, image cytometers, cell sorters and multiplex analyzers), as well as reagents used
to label the cells (antibody/hybridoma bank that provides commonly used, highest quality purified antibodies,
purification of existing monoclonals, and fluorescently coupled antibodies). Multiparameter analysis of single
cells has become a standard tool in cancer research. Flow cytometry technology now allows for the
measurements of more than 15 different markers simultaneously. With imaging flow cytometry (e.g., Amnis
ImageStream), the CAT Facility can also capture images of the analyzed cells and develop clinical or research
assays based on the expression of these markers as well as on their distribution. With mass cytometry, more
than 40 parameters on a single cell can be measured to obtain an unequalled amount of information for each
and every cell analyzed. Specific Core accomplishments during the current funding period include obtaining a
new BD FACsFortessa for 15 color flow cytometry, an Aria Fusion for sorting human samples for translational
studies, and a new CyTOF Helios mass cytometer that was funded by a successful NIH S10 award. The
Facility’s Scientific and Technical Directors provide direct oversight of the operation of the CAT Facility. A
Faculty Oversight Committee (FOC) also provides an advisory role to the Facility personnel with regards to
services, scientific direction and fiscal issues. The Office of Shared Research Facilities (OSRF) serves as the
home department for the Facility, providing IT and HR support, accountancy services, and strategic planning.
The Research Resources Oversight Committee (RROC) is a faculty committee that provides scientific and
financial oversight of all BSD Cores, and provides long-term strategic planning of Core services and resources.
Future plans for the CAT facility include improving direct contact with the research community to present
information about the Facility and better understand the needs of our user base, development of CyTOF
panels and reagents, and advancing as a cutting edge facility by incorporating new technology, while providing
our successful base core services.